Neural mechanisms of the glucocorticoid withdrawal syndrome

Abstract
The glucocorticoid withdrawal syndrome is increasingly recognized as a major barrier to the discontinuation of
chronic glucocorticoid treatment. This withdrawal syndrome contributes to widespread use of chronic
glucocorticoids, which are taken by 1-3% of the population despite high rates of adverse effects. The most
prominent symptoms of glucocorticoid withdrawal included generalized pain and decreased pleasure in
rewarding activities, which can only be managed by resuming high dose glucocorticoid treatment. There are no
available treatments for glucocorticoid withdrawal, and its mechanisms are unknown. We developed a novel
mouse model of glucocorticoid withdrawal to use for the first study of the neurobiological mechanisms. We
found that withdrawal increased pain sensitivity in both male and female mice while decreasing preference for
social contact in females. Thus, this model is capable of recapitulating some of the key aspects of the
syndrome in humans. One candidate neural circuit for linking these behavioral phenotypes is the mesolimbic
dopamine pathway, as it has been implicated in both pain and preference for natural rewards. Here we will test
the central hypothesis that the glucocorticoid withdrawal syndrome results from decreased activity in the
mesolimbic dopamine pathway. In Aim 1, we will more fully characterize the behavioral phenotype of
glucocorticoid withdrawal in our newly developed mouse model, focusing on pain sensitivity and preference for
natural rewards. To do this, we will use the von Frey and hotplate tests for pain sensitivity, and we will use
social interaction, food preference, and longitudinal home cage behavior to look at preference for natural
rewards. In Aim 2, we will investigate the role of the mesolimbic dopamine pathway in the glucocorticoid
withdrawal syndrome. We will determine how withdrawal alters activity of dopamine neurons in the ventral
tegmental area using in vivo calcium imaging. We will also test whether chemogenetic activation of these
neurons can rescue the behavioral withdrawal phenotype. This work will be the first study of the neural
mechanisms underlying the glucocorticoid withdrawal syndrome. Through these experiments, I will receive
essential training in 1) behavioral assays for pain in a rodent model, 2) chemogenetic neural circuit
manipulation 3) in vivo calcium imaging, and 4) computational modeling and analysis of big data sets. The
skills and training opportunities described in this proposal will enable me to become a successful scientist,
mentor, and educator in preparation for my future career in academia.

Public health relevance
Project Narrative: Chronic glucocorticoid treatment remains prevalent, with 1-3% of the US population taking synthetic glucocorticoids despite their associated adverse effects. Cessation of treatment is hindered by physical glucocorticoid dependence, with a withdrawal syndrome that is poorly understood. The proposed research will develop an animal model of glucocorticoid withdrawal and then use that model to investigate the underlying neural mechanisms, thus this reverse translational research will provide a foundation for the understanding of glucocorticoid withdrawal, which will ultimately lead to treatments for this public health-important condition.